The role of PARP10 in alleviating replication stress and promoting cellular proliferation and tumorigenesis

Project Summary
Identification of molecular pathways that are preferentially employed and relied upon by cancer cells compared
to normal cells is key to designing novel personalized cancer therapies. PARP10 is a poorly characterized
member of the PARP family. We previously showed that PARP10 promotes translesion synthesis (TLS)-
mediated bypass of DNA lesions during DNA replication, thereby alleviating replication stress. More recently,
we also showed that PARP10 is a novel oncogene. We found that the PARP10 gene is amplified and/or
overexpressed in a large number of tumors including breast and ovarian, with very few observed occurrences
of downregulation or loss. We found that the PARP10 gene is amplified and/or overexpressed in a large
proportion of human tumors including breast and ovarian, with almost no occurrences of downregulation or
loss. Moreover, we found that PARP10 overexpression in, non-transformed human epithelial RPE1 cells
results in enhanced proliferation, resistance to replication stress, and increased xenograft tumor formation in
immunocompromised mice. The opposing phenotypes were found upon knockout of PARP10 in cancer HeLa
cells. These findings suggest that PARP10 is a putative oncogene and its expression promotes tumor
formation and growth. Mutagenic TLS has been previously proposed to promote transformation by both
allowing hyper-proliferation and inducing genomic instability. Thus, we hypothesize that PARP10 expression
suppresses replication stress through TLS-mediated bypass of replication arresting structures, thereby
allowing hyper-proliferation of cancer cells. We propose here to directly test this, in three specific aims which
address the hypothesis at three different levels: Aim 1 will investigate the mechanism employed by PARP10 to
modulate PCNA-dependent TLS at the molecular level, using biochemical and cellular localization and
interaction assays. Aim 2 will functionally test the impact of this mechanism of cellular processes including
genomic stability and DNA replication. Aim 3 will employ a mouse genetic model to unambiguously investigate
if Parp10 expression induces tumor formation or promotes tumor growth. Using state-of-the-art cellular,
molecular and genomic tools (including: CRISPR/Cas9-mediated genome editing; molecular DNA fiber
combing to measure fork stability; next generation sequencing approaches to measure mutagenesis and
mutation burden) we will investigate here the molecular mechanisms underlying this novel oncogenic function
of PARP10. This may eventually result in validation of a new target for cancer therapy.

Public health relevance
Project Narrative PARP10 is poorly characterized human enzyme. In this application, we propose to investigate the molecular mechanisms underlying the potential oncogenic function of PARP10. This would result in validation of a new target for cancer therapy.